International Conference on Auditory Cortex (ICAC2025)

PROJECT SUMMARY
The goal of the International Conference on Auditory Cortex (ICAC2025) is to understand the auditory
cortical mechanisms that underlie higher-level hearing and auditory cognition and to use this knowledge to
mitigate hearing disorders that remain despite treatment with conventional hearing aids. In particular, the
organizers of ICAC are interested in attracting all scientists (especially young scientists, women scientists
and minority scientists) who (1) bring new methodologies and novel conceptual/theoretical approaches to
studies of auditory cortex; and (2) unify fundamental research on the structure and function of the auditory
cortex through a synthesis of human and animal research. Although there are many exciting convergent
results arising from non- invasive neuroimaging approaches in humans and invasive experimental
techniques in animals, there is still no full understanding of how to integrate knowledge from one field to
the others (such as optical imaging and neurophysiology in animals and EEG and fMRI in humans). One of
the key conference goals is to bridge these gaps between the insights gathered with different experimental
techniques in human and animalstudies.
ICAC has a unique constituency and forum: It is the only multi-day conference that focuses
exclusively on the contribution of the auditory cortex to perception and cognition. Further, because the ICAC
meeting takes place in a single conference setting without any parallel sessions, it maximizes formal and
informal scientific discourse in a collegial atmosphere. Thus, through this focused meeting, ICAC uniquely
spurs and facilitates scientific progress in auditory perception and cognition, communication, with a novel
combination of scientific breadth and depth, and provides a venue for relaxed and informal interactions
between scientists that spark ideas and future collaborations. Further, ICAC promotes meaningful and
educational interactions between junior and senior auditory neuroscientists throughout the program,
thereby helping to deepen and spur growth in our research pipeline and to provide career development
opportunities. Thus, ICAC is a unique venue for focused and in-depth discussions between junior and senior
scientists who are interested in the neural correlates of auditory perception and cognition. ICAC2025
continues a conference series that began in 2003 and rotates triennially between different international sites.

Public health relevance
PROJECT NARRATIVE Currently hearing impairment is treated by restoring ear functions with hearing aids or cochlear implants, which, unfortunately, have limited success in some individuals for a variety of reasons, one of which is that the role of the auditory cortex for auditory perception is often neglected. Thus, efforts are required to advance the understanding of the auditory cortex to find novel ways to improve the diagnosis and treatment of the range of auditory perceptual dysfunctions causing hearing impairment and that can lead to personal suffering and social isolation, as well as enormous annual healthcare costs of $133 billion in the US alone. The goal of the International Conference on Auditory Cortex (ICAC2025) is to bring together the worldwide leading scientists in this field to present, discuss and debate new findings in auditory cortical function and auditory cognition in humans and animals and apply these new insights to developing more effective new treatments for hearing disorders.